Enhancing Animal Welfare and Reproducibility of Biomedical Research at FAU

Florida Atlantic University's (FAU's) growing research enterprise, in particular in the biomedical
science, has put significant strain and demands on expanding and improving our animal care
operations. As part of this growth, FAU has implemented central research core oversight, which
includes the veterinary care unit, Comparative Medicine. Current operations include a policy,
rate structure and advisory committee oversight. A new vivarium is slated to come online in
2022. What is currently missing in this growing-demand environment is the support required to
update and modernize equipment. Yet, such modernization is desperately needed to improve
upon rigor and reproducibility of research data involving animals.
We here propose the acquisition of DVCTM racks to house mice in the new vivarium under the
most diligent conditions. These racks will allow the minute monitoring of animal support and
welfare via digitized monitoring, without disturbing the animals themselves. This will be
particularly important for mice housed in the new vivarium, as most of them are involved in
neurobehavioral studies, where slight disturbances can have a significant impact on research
data. The acquisition of these DVCTM racks will provide a significant boost to FAU's efforts to
improve and increase its research enterprise and improve the wellbeing of our animals.

Public health relevance
Disease prevention and treatment requires the use of animal models that can simulate effects before moving to a human-based study. Conditions in which animals are held have a tremendous impact on the results of such studies. This project will significantly improve on the wellbeing and thereby study design that governs animal model-based research.